Improving speech motor learning processes using augmented behavioral interventions

PROJECT SUMMARY / ABSTRACT
Speech disorders are the most prevalent form of communication disorders. Many treatments of speech
disorders involve learning new speech behaviors or modifying abnormal speech behaviors. These treatments
strongly rely on processes of speech motor learning—improvement in motor performance through practice.
However, speech disorders are often associated with impairments in various speech motor learning processes,
resulting in inefficient or deficient speech motor learning. Inefficiencies in speech motor learning processes
reduce the effectiveness of the treatments that rely on these learning processes. Therefore, there is a critical
need (1) to understand the specific contributions of each of the processes of speech motor learning and (2) to
develop behavioral protocols that selectively influence various motor learning processes to improve speech
motor performance. Without this knowledge, the promise of developing effective and optimized treatments for
speech disorders will likely remain limited. This proposal’s overall objective is to develop behavioral protocols
that selectively target and improve speech motor learning processes in healthy adults. Here, we propose a
research program to develop and optimize a set of visually augmented training protocols to improve the accuracy
of two processes crucial for successful speech motor learning: auditory error detection and auditory-to-motor
mapping. Our central hypothesis is that improving these processes through augmented training can improve
speech motor learning. We formulated this hypothesis based on current theoretical models of speech, including
our recent computational model. Aim 1 will evaluate the effects of error-detection training on speech motor
learning. Using visual feedback and auditory feedback perturbation, we will train subjects to detect and estimate
auditory errors more accurately. Subsequently, we will evaluate subjects’ extent of speech motor learning. Aim
2 will determine the contributions of auditory-to-motor mapping to speech motor learning. Using visual feedback,
we will train subjects to learn the relationship between various articulatory configurations and their auditory
consequences. Then, we will evaluate subjects’ extent of speech motor learning. This project’s results will have
a critical positive impact because (1) they will form a strong scientific foundation that can inform the development
of effective and optimized treatments for speech disorders, and (2) they will have significant theoretical
implications by elucidating processes of speech motor learning.

Public health relevance
PROJECT NARRATIVE Speech disorders negatively impact communication, reducing the overall quality of life and well-being of individuals with speech disorders. The proposed research is relevant to public health because the project’s findings will form a strong scientific foundation for developing theory-driven, effective, and optimized treatments for speech disorders. Additionally, this project will pave the way for developing more refined and complete theoretical perspectives of speech and speech disorders.